T cell Immunity in a Rare Juvenile Form of Motor Neuron Disease

PROJECT SUMMARY
Amyotrophic Lateral Sclerosis (ALS) is the most common form of motor neuron disease (MND).
Several reports have highlighted a link between some disease-causing genes and the immune
system. However, whether and how immune cells contribute to MND in specific forms of ALS is
yet to be defined.
Amyotrophic Lateral Sclerosis 4 (ALS4) is a rare and juvenile MND caused by mutations in the
gene SENATAXIN (SETX), which encodes for a nuclear helicase ubiquitously expressed that our
group identified as a transcriptional regulator of inflammatory response.
By using a mouse model of ALS4, we found that the hematopoietic system contributes to the
neurodegenerative process. Additionally, we discovered that CD8 T cells in the CNS and the
peripheral blood of disease-affected mice and patients are aberrantly activated. Our goal is to
define the role of CD8 T cells in disease initiation and progression. We will determine the function
of disease-associated CD8 T cells by transfer and depletion experiments and immune-histological
characterization in mice (Aim 1). We will assess molecular pathways of neuro-immune
interactions during disease by network modeling of transcriptomic and correlation-structure
analyses (Aim 2). Finally, we will validate the presence of activated CD8 T cells in mouse models
and patients with other forms of ALS (Aim 3). Our
contribution
of
results will provide a deeper knowledge of the
of CD8 T cells in ALS and open potential avenues for their use as immune biomarkers
disease progression and as novel therapeutic target.

Public health relevance
PROJECT NARRATIVE No treatments or biomarkers are available for motor neuron disorders (MND) because our understanding of the etiology of these diseases is still limited. The proposed research aims at investigating the role of the adaptive immune system in the rare, juvenile MND ALS4 (Amyotrophic Lateral Sclerosis 4) by using both mouse models and patient's samples. The knowledge that will be generated from this research project will contribute to define whether T cells contribute to ALS pathology and can be used as biomarkers of disease progression.